IR502 THERAPEUTIC VACCINE IN PATIENTS WITH PSORIASIS VULGARIS--PARTS A AND B

Recent evidence suggests that CD8+ T-lymphocytes of the Vbeta 3 or Vbeta 13.1 subsets are activated and clonally expanded in skin lesions of psoriasis vulgaris. This study is a clinical and pathological examination of potential disease-mediating functions of these T-cell subsets. The study involves administration of a bivalent peptide vaccine containing epitopes from Vbeta 3 and Vbeta 13.1 constant regions to patients with chronic psoriasis vulgaris. Part A of the study is concerned with clinical evaluation of outcomes. Part B of the study is concerned with assessment of T-lymphocyte subsets in psoriatic skin lesions before and during treatment, as assessed in skin biopsies.